A portable quantitative polymerase chain reaction platform (qPCR) for rapid detection of pathogens impacting model organisms in animal facilities

Project Summary
In recent years there have been growing concerns about the rigor and reliability of data originating from
common and critical animal model experimentation. In fact, a core principal of science – reproducibility – has
been called into question largely due to challenges in replicating biologically complicated animal experiments.
We have developed a fast, portable, quantitative PCR (the current universal “gold standard” method) device
for use in a wide variety of diagnostic settings. We believe that our rapid, handheld, battery-powered and
wireless device has the potential to empower rapid diagnostics around the world. In this proposal we aim to
validate the use of our prototype device using real-world samples for microbial pathogen detection.
Regarding our innovative technology, we have taken a fundamentally different approach to heating and
cooling the sample being amplified, avoiding the standard Peltier heating block. The heat transfer is so
efficient that we are able to perform a heating and cooling cycle in as little as 15 seconds (possibly even
faster), resulting in a 40-cycle run finishing in about 11 minutes.
In essence, this means you can get a quantitative answer regarding the presence and abundance of your
target pathogen with ultimate sensitivity significantly faster than the current state of the art.
Looking deeper into the root causes of animal-derived data variability is pointing to several possible
environmental and biological causes. In terms of the biology, microbes that live inside or outside of the body
are proving to have clear and present effects on experimental outcomes, yielding data that is inconsistent and
questionable. In particular, when the studies of interest are translational by design, and therefore intended to
benefit / improve human health, there is even greater cause for concern.
We are poised to test our device to identify and quantify the presence (or absence) of pathogens in an fully
operating academic animal facility at UC Berkeley. Together with the Office of Laboratory Animal Care, we
have identified two important and tractable pathogens as good candidates for initial proof of principle studies:
Helicobacter species (bacteria) in mice and B. dendrobatidis, a fungus affecting amphibians.

Public health relevance
Pathogens infecting or invading commonly used model organisms has the potential to negatively impact results, reproducibility, and subsequent success of human clinical trials. It is critical for animal care facilities to monitor to the greatest extent possible the real time presence or absence of such microbes, particularly in rodent facilities, but also in other “barrier” protected areas spanning the gamut of model organisms. Providing simple, fast, easy-to-use, quantitative detection of the most virulent and consequential pathogens helps to ensure the validity and value of the data collected from these essential model organisms, and empowers animal care facilities to quickly respond to and address concerns before they become serious threats.